Neurobehavioral effects of cannabidiol in youth alcohol use disorder

PROJECT SUMMARY/ABSTRACT
Alcohol use is prevalent and problematic among youth, who are more likely than adults to initiate alcohol
use, develop alcohol use disorder (AUD), and suffer lasting adverse alcohol-related consequences. Despite the
clear need for youth-targeted AUD treatments, established psychosocial and behavioral interventions offer
limited efficacy, with very few youth achieving sustained alcohol abstinence or reduction. Pharmacotherapies
play a key role in bolstering substance use disorder treatment outcomes in adults, but to date, no medications
for AUD in youth have merited FDA approval. The development of safe and effective adjunctive medications to
treat adolescent AUD is needed to improve treatment outcomes and to potentially reduce the long-term
consequences of adolescent use. Cannabidiol (CBD), one of the main phytocannabinoids in the Cannabis sativa
plant, is a potentially promising candidate pharmacotherapy for youth AUD. It is particularly appealing as a youth
treatment option since it is non-intoxicating, appears generally well-tolerated, and demonstrates no signal of
abuse liability. CBD has many potential targets within the central nervous system that may mitigate the symptoms
of AUD via modulation of the glutamatergic, GABAergic, dopaminergic, opioidergic, and endocannabinoid
pathways. Preclinical work has shown that CBD affects an array of drinking behaviors (e.g., reduces ethanol
seeking and intake; mitigates symptoms of withdrawal, relapse, anxiety, and impulsivity), and recent clinical work
has indicated CBD's potential to reduce alcohol intake within adults who endorse alcohol and cannabis co-use.
Establishing the acute neurometabolic, neurobehavioral, and psychophysiological effects of CBD in youth with
AUD will be a critical first step in the pharmacotherapy development pipeline before initiating larger scale trials.
The goal of this application is to test CBD as a potentially effective candidate medication for youth AUD by
leveraging developmentally informed neuroimaging methods (magnetic resonance spectroscopy and functional
MRI) and lab-based alcohol cue reactivity procedures. To accomplish this goal, this study will use a randomized,
double-blind, within-subjects crossover design. In counterbalanced order, 35 youth (ages 14-24) who meet
criteria for AUD will receive 600 mg of CBD or placebo with a standardized meal (to modulate CBD absorption
rates) three hours before a neuroimaging and behavioral assessment paradigm, separated by a 13-day washout
period. This proposal is consistent with the trans-NIH initiative to identify neurally-informed novel substance use
treatments for youth. Findings will bridge a critical translational gap (“the valley of death”) in pharmacotherapy
development for youth AUD, advancing methodology for rigorous neural-behavioral early efficacy testing of CBD.
Effects established through this study could pave the way to a larger-scale clinical trial and, ultimately, improved
long-term outcomes for young people suffering from AUD.

Public health relevance
PROJECT NARRATIVE This project is a critical step in assessing the effects of cannabidiol as a candidate medication treatment for youth alcohol use disorder. Medications could help bolster psychosocial interventions for youth struggling with alcohol use problems and reduce the likelihood of transitioning into severe, persisting alcohol use disorder in adulthood, thereby significantly reducing costs to the healthcare system and society.